Helium Recycling for UIC Nuclear Magnetic Resonance

Project summary
Nuclear magnetic resonance (NMR) is a critical technique for characterization of small molecules such as
proteins, including their structure, dynamics monitoring and quantitative analysis, among others. For proper
operation of NMR instrumentation, cryogenic liquids such as helium are necessary to maintain low
temperatures required for operation. Helium is a limited natural resource and much of the cryogenic liquid used
for instruments such as NMR is released to the atmosphere during both routine operation and occasional
magnet fills. To address this issue, commercial vendors have developed helium gas capture and recycling
systems to be able to address the boil off loss. At the University of Illinois Chicago (UIC), our shared NMR
instrument core, located in the Center for Structural Biology, houses three NMR spectrometers with an
additional instrument planned for installation in the coming months. Thus, this facility demands substantial
liquid helium, which is both costly and uses a depleting natural resource. In response to this funding
announcement, we are proposing to prepare the site and install a helium recycling unit that has multi-
instrument capabilities in the Center for Structural Biology. The addition of this new system will streamline our
operations, modernize our facility and enable an increased user base for this shared facility.

Public health relevance
Project Narrative The enclosed application seeks to upgrade and modernize a shared facility that uses cryogenic helium. The development of capture and recycling systems for helium has provided a means to reduce the demand on this natural resource. Placement will be in a nuclear magnetic resonance facility which supports research across our campus including biomedical and health related studies.